Neonatal EEG MOnitor (NEMO) Phase IIb

Abstract
Neonatal seizures occur in over 14,000 newborns annually in the US, and are frequently
associated with long-term deleterious consequences including intellectual disability, epilepsy,
and other neurodevelopmental disabilities. Electroencephalography (EEG) is the only reliable
means of detecting seizures; however, many Neonatal Intensive Care Units (NICUs) do not
have the capability to do EEG recordings due to the lack of skilled EEG technicians to apply gel-
based electrodes to delicate neonatal skin and acquire clean signals.
Under NIH SBIR funding, Quantum Applied Science and Research (QUASAR), a leader in
noninvasive sensor technology, in collaboration with Children’s National Hospital (CNH), a top
ranked pediatric hospital, has been developing a Neonatal EEG MOnitor (“NEMO”) device
intended as a reliable and easy-to-use EEG system that will increase availability of neonatal
EEG monitoring to hospitals that typically lack this capability. The NEMO device takes
advantage of QUASAR’s innovative dry sensing technology combined with a soft cap that is
designed for minimal impact on the infants’ wellbeing and ease of use in the hospital
environment. NEMO will lead to more neonates being screened and treated, and thus to shorter
hospital stays and improved outcomes.
Under Phase I and Phase II of this project, QUASAR and CNH have validated QUASAR’s dry
electrodes for the neonatal monitoring application in a NICU environment, demonstrating their
signal quality was comparable to that of wet electrodes, and built a prototype NEMO headset.
The main goal of the proposed Phase IIb effort is to finalize the NEMO device, validate its
performance on neonates in the NICU environment, and obtain 510(k) clearance for it. In order
to accomplish this goal, QUASAR will work with ProPharma, a regulatory consultant firm, to
establish current Good Manufacturing Practices (cGMP) and finalize the NEMO device under
cGMP. QUASAR will then complete Safety Testing, and in collaboration with CNH will conduct
a Clinical Validation to obtain the necessary data for a 510(k) submission. The final step in the
project will be a product launch in partnership with medical device manufacturers and
distributors.

Public health relevance
Narrative Seizures are a common neurological disorder in infants occurring in some 14,000 newborns annually in the US. Early detection and treatment can result in more effective seizure control and lower rates of morbidity and mortality. Quantum Applied Science and Research (QUASAR), in collaboration with Children’s National Hospital (CNH), propose to develop an innovative Neonatal EEG MOnitor (“NEMO”) system intended as a reliable and easy-to-use EEG system that will increase availability of neonatal EEG monitoring at all hours of the day and to hospitals that typically lack this capability. This advance will lead to more neonates at risk for seizures being quickly screened and appropriately treated, which in turn is expected to shorten hospital stays and improve outcomes.